PHASE II CLINICAL TRIALS OF NEW CHEMOPREVENTIVE AGENTS

Conduct Phase II clinical trials of chemopreventive agents. Provide the drug development data to allow approval of the drug for larger clinical chemopreventive studies.